Estrogenic modulation of neural circuits that control temperature

PROJECT SUMMARY
Estrogen withdrawal at menopause is associated with a suite of metabolic, vascular, and neuroendocrine
changes that impact health and quality of life. The most specific symptoms associated with menopause are
vasomotor symptoms, which include hot flashes and night sweats. It is thought that vasomotor symptoms are
caused by fluctuating estrogen levels at the time of the menopausal transition. However, it is unclear how
these changes affect temperature regulation in the brain. Our preliminary data identify a thermoregulatory role
for neurons that express estrogen receptor alpha (ERalpha) in the medial preoptic area (MPO) of the
hypothalamus, a potent temperature sensor and regulator. We hypothesize that ERalpha signaling in the MPO
modulates the activity of thermoregulatory neural circuits. To test this hypothesis, we propose the following
specific aims: 1) Define the thermoregulatory role of ERalpha+ neurons and ERalpha signaling in the MPO, 2) Dissect
the neural circuitry that mediates estrogen-induced changes in heat dissipation and generation, and 3)
determine the transcriptional effects of estrogen signaling in thermoregulatory ERalpha+ neurons. Together these
studies will dissect the effects of estrogens on temperature regulation at the level of circuits, neurons, and
gene expression. This mechanistic approach is essential for understanding how estrogens alter body
temperature and is a necessary first step toward identifying new non-hormonal therapies for hot flashes and
other vasomotor symptoms.

Public health relevance
PROJECT NARRATIVE Hot flashes and night sweats are associated with fluctuating estrogen levels during the menopausal transition but it is unclear how changes in estrogen signaling lead to hot flashes. We hypothesize that estrogen signaling alters temperature regulation through a region of the hypothalamus that is temperature-sensitive, rich in estrogen receptor expression, and controls heat dissipation and generation. The proposed studies will dissect the effects of estrogens on this thermoregulatory center and identify estrogen-dependent cellular mechanisms that may provide new targets for future therapies against hot flashes.